Sequencing Core

In this core, Dr. Bumgarner's group will be responsible for performing sequencing analysis of viral populations isolated from a primate model of hematopoetic cell transplant (HCT) aimed at a targeted cure for HIV.

Public health relevance
The underlying hypothesis being tested it that conditioning and HCT regimens that do not eliminate the latent reservoir will bias the remaining virus toward more ancestral sequences, and sequences representing anatomic sites (for example, GALT or CNS) containing the most persistent reservoir. We will perform genetic analysis on viral sequences obtained from blood, cerebral spinal fluid, and the intestinal tract, before and at intervals during the year after HCT to test this hypothesis.